Geriatrics Research: From Bench-to-Bedside

PROJECT SUMMARY/ABSTRACT
Resilience, defined as the ability to respond to stressors, declines with age and co-morbid conditions in older
organisms. To date, little progress has been made to improve our understanding of resilience with aging and
its multi-component dimensions in response to physical, cognitive, and social stressors, in part because
resilience itself is likely a dynamic multi-systemic process that is most evident under conditions of stress. This
application is for a five-year cooperative conference grant to continue the successful “Geriatrics Research:
Bench-to-Bedside” series. The series has had an outstanding impact. Past conferences represented
“paradigm-shifting” moments and “pivotal” junctures in areas such as frailty, multimorbidity, and delirium. Here
we propose to build bridges and bring together resilience scientists and experts from the physical, cognitive,
and social domains to discuss, debate, and learn from each other the dynamic multi-component phenomena of
resilience. In the first conference, Overview of the Resilience World: State of the Science, we will focus on
setting the stage and discuss working definitions of resilience from physical, cognitive, and psychosocial fields.
A goal will be to identify areas of commonalities and differences and how we can operationalize a shared
concept so that “resilience” can be quantified appropriately in different contexts. In the second conference,
Stress tests and Biomarkers of Resilience, we aim to discuss resilience stress test paradigms and
molecular markers that may be associated with resilient outcomes. Building on the first conference, this
conference will refer to operationalized definitions of resilience and resilient outcomes, acknowledging that
definitions may differ slightly across fields and contexts. Lastly, the third conference is entitled Optimizing
Resilience. By integrating the foundation built in the first two conferences, we will focus on interventions to
optimize resilience in older adults. This conference series, once completed, will serve as a forum and a
unifying thread that will bring together national research leaders to build an integrative multidimensional
understanding of resilience in older organisms.

Public health relevance
PROJECT NARRATIVE The population of older adults in the United States is expanding as is the understanding of the basic biology that underlies the many clinical changes that happen to older people. The overall focus of this proposal is to support efforts to continue the successful “Geriatrics Research: Bench-to-Bedside” conference series, focusing on elucidating of phenomena of resilience with aging and its multi-component dimensions in response to physical, cognitive, and social stressors. This series encompasses sharing of knowledge, exchanging new ideas,education, mentorship and exploring recent developments as well as defining knowledge gaps and priority future research directions.